Function of PD-1 Signaling on the Activity of B cells in the Tumor Microenvironment in Breast Cancer

ABSTRACT
The success of PD-1-targeted immune checkpoint inhibitor (ICI) therapy has revolutionized cancer treatment,
becoming a new standard of care for various types of cancer. However, the treatment outcomes for triple
negative breast cancer are still limited. To enhance the efficacy of checkpoint inhibitor therapy, it is important to
gain a deeper understanding of PD-1 regulation in the tumor microenvironment.
B cells in the tumor immune microenvironment have been understudied, despite their growing recognition as key
players in shaping the tumor microenvironment. The presence of tumor-infiltrated B cells indicates the prognosis
of many types of cancer. Interestingly, our previous research in pre-clinical models has shown that the sensitivity
to dual ICI therapy, including the PD-1-targeted treatment, is dependent on B cells, and to a lesser extent, CD8+
T cells. These findings emphasize the importance of studying the PD-1 signaling in B cells to improve the clinical
outcomes of checkpoint inhibitor therapy.
The goal of this study is to understand how PD-1 signaling pathway regulates B cells in the tumor
microenvironment. One of the main mechanisms for PD-1 to modulate T cell function is through reprogramming
T cell metabolism, allowing them to meet the energy requirements needed for differentiation into various
subpopulations. We hypothesize that the PD-1 activation on tumor-infiltrated B cells alters the metabolic program
and B cell fate decision similar to T cells. PD-1-targeted therapy potentially impacts B cells in proliferation,
survival, differentiation, and function through metabolic reprogramming, which serve as a main mechanism for
PD-1 to regulate the antitumor function of B cells. Aim 1. To evaluate our hypothesis, we will dissect how PD-
1-targeted therapy modulates B cell differentiation through metabolic switch ex vivo. We will combine primary
murine B cell culture with state-of-the-art metabolic profiling tools to determine if and how PD-1 blockage directly
altered B cell differentiation and metabolism. This approach allows the evaluation of the glycolysis and fatty acid
metabolic machinery in B cell to control these cells differentiation into germinal center B cells, antibody-secreting
cells, and other functional subsets of B cells. Aim 2. We will use PD-1 fate mapping mice (PD-
1Cre/tdTomato.Rosa26floxp-YFP) and transgenic breast cancer models to examine how PD-1-blockage guides B cell
fate decisions and function in vivo. Elucidating the interaction between B cells and the PD-1 signaling pathway,
which has so far escaped the attention of the cancer immunology field, would strongly enhance the clinical
activity of ICI therapy in tumors where B cells are critical to the anti-tumor response.

Public health relevance
PROJECT NARRATIVE Immune checkpoint inhibitor therapy, such as PD-1 blockade therapy, has substantially improved the treatment of triple negative breast cancer but limitations persist. Investigating understudied components in the tumor microenvironment, such as B lymphocytes, could improve clinical outcomes and inform future therapeutic studies. Our preliminary data suggest that PD-blockade therapy could regulate the antitumor function of B lymphocytes, and additional investigation is needed to better understand this mechanism.